The role of muscle-derived extracellular vesicles in adipocyte metabolism

Extracellular vesicles (EVs) are membrane-bound vesicles released by virtually all cell types, potentially
mediating intercellular communication and thereby play essential roles in many physiological and pathological
processes. This capacity relies on EVs’ ability to serve as delivery vehicles for a wide range of endogenous
cargo molecules, such as RNAs, proteins, and lipids. EVs have also been found to display tissue-specific
recognition mediated by surface molecules (such as integrins and glycans), making them promising for drug
delivery applications. However, a better understanding of EV composition and cargo is necessary to enable the
use of EVs as delivery vehicles. Preliminary data demonstrate that after a hypertrophic stimulus, muscle-derived
EVs (mEVs) are specifically delivered to adipose tissue. Interestingly, the delivery of mEVs to adipose tissue
induced lipolysis and fat loss in high-fat-diet-fed mice. This exciting preliminary data could represent the first
steps into the development of therapy for obesity. Additionally, our preliminary data indicate high levels of
diacylglycerol (DAG) within mEVs, which could, upon delivery, mediate protein kinase C (PKC) activation and
induce changes in adipocyte metabolism. The proposed project expands upon our preliminary data and is based
on the overarching hypothesis that a hypertrophic stimulus would change the lipid makeup of mEVs, leading to
adipocyte metabolism changes. More specifically, it is hypothesized that a hypertrophic stimulus will increase
DAG concentration within mEVs that will induce adipocyte lipolysis through PKC activation, resulting in wholebody
metabolic benefits. In order to confirm our preliminary data, we will use muscle cells (C2C12 cells) to
isolate mEVs with or without a hypertrophic stimulus (treatment with insulin-like growth factor 1) and perform a
lipid profile of these vesicles. After establishing the lipid profile, mEVs will be transferred to adipocyte cells
(3T3L1 cells) or will be tail vein injected into obese mice. The purpose of this project is to test this working
hypothesis by pursuing three specific aims. Specific Aim 1 is to determine whether the lipid composition of
skeletal muscle extracellular vesicles is altered in response to a hypertrophic stimulus; Specific Aim 2 is to
determine whether mEVs stimulate adipocyte lipolysis through PKC activation; and Specific Aim 3 is to
determine whether extracellular vesicles in response to a hypertrophic stimulus can induce fat loss through
enhanced lipolysis in obese mice. Preliminary data suggest that mEVs provide beneficial effects on adipocyte
metabolism and induce fat loss in obese mice. If the results of the proposed experiments provide evidence to
support the hypothesis, a future R01 application will seek to rigorously test which class/classes of lipids can
specifically mediate changes in adipocyte metabolism.